Implementation of Childhood Obesity Treatment Innovations to Improve Outcomes of Low-Income Children: The Connect for Health II Study

Project Summary/Abstract
Cardiovascular disease is the leading cause of death and premature mortality in the US and worldwide.
Obesity is a major contributor to cardiovascular disease and has its origins in early life. Thus, interventions to
reduce obesity and adverse risk factors in childhood may set individuals on the best possible trajectories for
lifelong cardiovascular health. Promising approaches for reduction of childhood obesity include interventions
such as Connect for Health which demonstrated that a highly scalable, multilevel intervention package
including (1) electronic health record (EHR)-based clinical decision support tools to guide pediatric clinicians in
child weight management; (2) family educational materials focused on evidence-based behavioral targets; and
(3) social- and community-informed text messages for parents to support behavior change, could improve
family-centered outcomes for childhood obesity and child body mass index (BMI). Despite availability of
proven-effective interventions such as Connect for Health, substantial gaps remain in the adoption of
recommended practices by clinicians and families, particularly in settings that care for low-income children.
Implementation strategies that leverage efficient health information technologies (HIT) can help support
adoption of effective interventions among clinicians and families. Incorporation of HIT may be especially
effective if augmented by outreach to parents and children, yet we have insufficient evidence on facilitators and
barriers to the adoption of behavior change recommendations and ways to support and sustain behavior
changes among diverse patient populations. Finally, few studies attempt to learn modifiable attributes of
clinicians and families who demonstrate “positive deviance”, i.e. those who have succeeded in making practice
and behavior changes in the context of sometimes inflexible clinical workflows and/or adverse neighborhood
environments. The purpose of this study is to develop and test implementation strategies to accelerate the
uptake and adoption of research evidence generated by the Connect for Health trial among pediatric primary
care teams and families. Guided by the Reach, Effectiveness, Adoption, Implementation, Maintenance (RE-
AIM) and Consolidated Framework for Implementation Research frameworks, we will use mixed-methods to
adapt and implement the Connect for Health intervention in two large health care systems in Massachusetts,
examine generalizable and modifiable attributes and strategies associated with positive deviance (e.g. children
who achieve clinically significant improvements in BMI and clinicians who adopt the program with high fidelity),
and examine the costs associated with the intervention. To achieve our aims, we have assembled a research
team with extensive experience in obesity interventions, implementation science, informatics, community
health, biostatistics, and qualitative methods. If successful, this study will yield evidence of proven, cost-
effective, sustainable, and generalizable strategies for accelerating adoption of evidence for obesity screening
and management in pediatric primary care and for improving outcomes for low-income children with obesity.

Public health relevance
Project Narrative Childhood obesity is prevalent, of consequence, and disproportionately affects racial/ethnic minorities and children from disadvantaged backgrounds. Despite availability of proven-effective interventions that aim to improve clinical management of children with obesity and support families in behavior change, substantial gaps remain in the adoption of recommended practices by clinicians and families, particularly in settings that care for low-income children. The goal of this study is to develop and test implementation strategies to accelerate the uptake and adoption of research evidence generated by the Connect for Health trial and ultimately improve quality of care and outcomes for low-income children with obesity.